The coordination of miRNAs in axon guidance

Proper axon outgrowth and pathfinding is essential for establishing precise neural networks during
development. Defects in axon guidance are implicated in a variety of neurological disorders.
Spatiotemporal regulation of guidance receptor expression facilitates differential responses of neurons to
guidance cues in order to form accurate neuronal wiring. In vertebrates, levels of the guidance receptor
Robo1 are low in precrossing and high in postcrossing commissural axons (CAs), functioning as a
‘molecular switch’ to regulate sensitivity to Slit repulsion and guide CA midline crossing. However, the
mechanism underlying the fine-tuned spatiotemporal regulation of Robo1 expression remains largely
unknown. MicroRNAs (miRNAs) regulate target gene expression by binding specifically to the three prime
untranslated region (3’UTR) of target mRNAs, thus repressing translation and/or inducing
mRNA degradation. Our recent studies indicate that the chicken Robo1 (cRobo1) 3’UTR is required
for regulation of protein expression in the developing spinal cord, and miR-92 represses cRobo1
expression to regulate Slit sensitivity thereby controlling CA projection and midline crossing.
Interestingly, miR-219a, another highly conserved miRNA, also suppresses cRobo1 expression. Ectopic
expression of miR-219a in postcrossing commissural neurons results in stalling of CAs in the floor plate.
Therefore, we propose that both miR-92 and miR-219a function as negative regulators of Robo1
expression in CAs by targeting its mRNA at the 3’UTR to control Slit/Robo1-mediated CA projection
and midline crossing. To test this hypothesis, we will first determine whether endogenous
miR-219a specifically regulates cRobo1 expression in commissural neurons of embryonic chicken
spinal cords during midline crossing (Aim 1): we will (1) determine the temporospatial expression
patterns of miR-219a and cRobo1 in commissural neurons, (2) examine the activity of endogenous
miR-219a in precrossing commissural neurons of chicken spinal cords, and (3) untangle the
mechanisms underlying miR-219a-mediated repression of cRobo1. Secondly, we will focus on
studying the functional importance of miR-219a in Slit/Robo1-mediated CA outgrowth and turning in
vitro and CA projection and pathfinding in vivo (Aim 2). Finally, we will investigate the collaboration of
miR-92 and miR-219a in repression of cRobo1 expression in Slit/Robo1-mediated spinal CA guidance
(Aim 3): we will examine the collaboration of miR-92 and miR-219a in (1) suppression of cRobo1
expression by targeting its 3’UTR, (2) regulation of cRobo1 local protein synthesis in CAs, (3) Slit/
cRobo1-mediated CA guidance. These proposed experiments will provide a novel model that specific
miRNAs collaboratively suppress Robo1 expression, thereby modulating Slit sensitivity to
control Slit/Robo1-mediated CA guidance during embryonic spinal cord development.

Public health relevance
The precise wiring of the nervous system relies on proper axon outgrowth and pathfinding during development. MicroRNAs (miRNAs), a highly conserved class of small non-coding RNAs, regulate gene expression to control neuronal development. Studying the role of miRNAs in axon guidance will not only help us understand how the brain forms complex and precise connections during development, but also provide a basis to design new strategies for rescuing the axon guidance defects in neurodevelopmental disorders.